DEVELOPMENT OF CHICKEN PALATAL TASTE BUDS

The development of chicken palatal taste buds was studied by means of tritiated thymidine autoradiography. Chick embryos were injected with tritiated thymidine in ovo and sacrificed at 5-day intervals from embryonic day 21 to post-hatching day 2. Palatal tissue was fixed and processed for electron microscopy, then thick sectioned at 4 micrometers and examined in the light microscopy, then thick sectioned at 4 micrometers and examined in the light microscope to locate the taste buds. The thick sections were re-embedded and sectioned at .25 micrometers, then processed for EM autoradiography. After exposure times of 3 to 6 weeks, the .25 micrometer sections were examined with the HVEM to locate labelled taste bud cells and to characterize these cells.